Diversity Supplement: The Role of Executive Functioning in the Health of Adolescents at-risk for Type 2 Diabetes

Project Summary
Adolescent-onset type 2 diabetes (T2D) is on the rise and a leading cause of severe medical
complications, premature morbidity, and early mortality, particularly among adolescent girls of
color. Treatment is challenging, making prevention a high priority. Yet, standard lifestyle
interventions aimed at preventing T2D show insufficient effectiveness. Extant interventions likely
fall short, at least in part, because they primarily focus on directly modifying health behaviors
(e.g., physical activity), without addressing the role of broader, developmentally-salient core
principles that propel health behavior change. It is critical to identify novel modifiable targets.
Extant theory and empirical data suggest that one such target is executive functioning (EF), a
set of neurocognitive skills key for executing goal-directed behavior. The aims of this Diversity
Supplement application are 1) to examine within-person EF and stress as antecedents of same
day and next day changes in physical activity, and 2) to characterize temporal dynamics
between EF, stress, and physical activity. Knowledge gained from completion of this project will
help guide the development and optimization of future, tailored T2D preventive interventions
that leverage neurocognitive processes and the promise of “just-in-time” adaptive interventions
(i.e., tailored interventions that provide the right type and amount of support, at the right time,
based on an individual’s real-time internal state) as a supplement or alternative to traditional
lifestyle approaches. This 2-year Diversity Supplement will also support the career development
and research program of the candidate, an early-stage diverse investigator, by providing
specialized training and access to outstanding mentors, the resources of premier research
institutions, and a committed team dedicated to advancing the training and development of
promising behavioral scientists. Together, the research and career development plans outlined
in this proposal will allow Dr. Gutierrez-Colina to develop a programmatic line of research and
the skills necessary for the submission of a future NIDDK career development (K) award that
will facilitate her transition to independence.

Public health relevance
Narrative The proposed project will elucidate how within-person changes in stress and executive functioning account for variations in physical activity among adolescent girls at risk for type 2 diabetes (T2D). This study will also provide a comprehensive characterization of the time- ordered dynamics between executive functioning, stress, and physical activity in this vulnerable population. Our findings will offer critical data to guide the development and optimization of future, tailored T2D preventive interventions that leverage individual neurocognitive processes to address the unique and real-time internal states that hinder engagement in physical activity among adolescents at risk for T2D.